3D Printed Collagen Tracheal Scaffolds with Biomimetic Microstructure

PROJECT SUMMARY/ABSTRACT
Approximately 1 in 2000 children are born with a congenital airway malformation and others develop tracheal
defects due to disease or trauma; an important subset of these patients needs a tracheal graft to regain airway
patency. Many impactful discoveries and innovative strategies have resulted from over 75 years of research into
development of a tracheal replacement, but there remains a need for a tracheal graft that is patient-specific and
can provide long-term, intervention free treatment while growing with the patient. The research goal of this
fellowship is to engineer a patient-specific, 3D bioprinted collagen tracheal graft that recapitulates the mechanical
properties of native trachea by incorporating biomimetic microstructure. 3D bioprinting is a technology ideally
suited for tackling this challenge, as it allows us to use native biological materials, like collagen type I and
decellularized tracheal ECM, to construct grafts that exactly match patient anatomy. The Feinberg lab has
developed a new generation of Freeform Reversible Embedding of Suspended Hydrogels (FRESH) bioprinting
that will allow me to control the microstructure of printed scaffolds to reproduce the extracellular matrix
organization found in native trachea. By matching regional tracheal mechanics to physiologic loading using 3D
patterned biomimetic microstructure, this proposal will take an important step towards a durable, patient-specific,
immunosuppression free treatment for long-segment tracheal defects. In the first aim I will use high resolution
volumetric imaging to interrogate native tracheal extracellular matrix microstructure. These data sets will be used
to design regionally appropriate biomimetic microstructures for different sections of the trachea (e.g. ring,
connective tissue). These microstructural patterns are expected to recapitulate physiologic mechanical
properties in both finite element analysis (FEA) models and 3D bioprinted collagen constructs. In the second aim
I will use age-specific tracheal measurement data and deidentified medical imaging datasets to produce patient-
specific pediatric tracheal graft geometries using open-source imaging segmentation tools. Regionally
appropriate biomimetic microstructure will be patterned throughout these graft geometries. These biomimetic
tracheal grafts will be modelled in FEA and then printed in collagen and mechanically characterized (e.g.
collapsing forces, compliance, suturability) to demonstrate recapitulation of physiologically essential native
tracheal mechanics. To accomplish this research, I have assembled a team with significant expertise in
biomechanics, developmental biology, tissue engineering, and extracellular matrix. I have worked with this team
to develop a rigorous training plan that will take advantage of the world class environment of Carnegie Mellon
University and the University of Pittsburgh to help me build the technical and professional skillsets necessary for
a productive physician-scientist. This proposal will jumpstart my long-term goals of investigating regenerative,
functional tissue scaffolds for treatment of congenital, traumatic, and oncologic head and neck tissue defects
while practicing as an otolaryngologist with a subspecialization in head and neck surgery.

Public health relevance
PROJECT NARRATIVE Approximately 1 in 2000 children are born with a congenital airway malformation and still more develop tracheal defects from trauma and malignancy; an important subset of these patients will require a tracheal graft to regain a functional airway, but improved tissue engineering and biofabrication techniques are required for their long- term success. This proposal aims to use a new development in collagen 3D bioprinting, Freeform Reversible Embedding of Suspended Hydrogels (FRESH), to incorporate biomimetic microstructure into a patient-specific tracheal graft for recapitulation of native airway mechanics. Reproducing a mechanically functional tracheal graft with FRESH will be an important step towards tissue engineering an airway that can grow with the patient and be successfully remodeled into healthy tissue.